Individualized Assessment and Treatment Program for TMD: Coping as a Mechanism

Temporomandibular/orofacial pain disorders (TMD) are a group of painful conditions with multiple
determinants. A number of psychosocial treatments for TMD have been developed, but overall
effectiveness has been limited, and the mechanisms of treatment are unknown. This proposal has two
main goals: 1) to develop a highly individualized, adaptive treatment for TMD that has potential to be
more effective than other psychosocial treatments; and 2) to discover the mechanisms by which
psychosocial treatments work in chronic pain. Patients with TMD-related pain of at least 3 months
duration (N=160) will be randomly assigned to either a Standard Conservative Treatment +Cognitive
Behavioral coping skills treatment (STD+CBT), or to an Individualized Assessment and cognitive-
behavioral Treatment Program (IATP) for patients with TMD pain. Treatment in IATP will be based on a
very detailed functional analysis of the patient's pain experience, in context, as derived from Experience
Sampling (ES). The ES procedure will be conducted via smartphone app at a rate of 4 records per day,
and will be used to gather information on patients' pain, momentary cognitions, affects, and coping
behaviors, for a 2-week monitoring period prior to the beginning of treatment. Therapists will use this
information to develop an individual functional analysis of pain and non-pain episodes, and determine
what thoughts, feelings and actions are effective for that patient at managing pain and which are not.
The information will be used to help develop adaptive coping tactics in a 6-session treatment program,
offering skills training tailored to specific patient needs. During-treatment ES will allow adjustment of the
treatment goals and procedures, making the treatment adaptive and able to change with changing
circumstances and patient needs. This experimental treatment (IATP) will be added to a standard
conservative splint-based treatment for TMD pain (STD). The combination (STD+IATP) will be
compared to a STD treatment supplemented with a 6 session conventional cognitive-behavioral
program not based on in-vivo assessment of pain and coping. In the STD+CBT condition ES data will
be collected but will not be used to inform treatment, but will control for measurement reactivity. ES
data collected prior to, during, and following both treatments (out to 12 months) will allow very precise
measurement of cognitions, affects, and coping skills, as they occur in patients' home environments,
and how they change over time. Outcomes will include measures of pain, interference, and depressive
symptoms. The study will be able to tailor treatment based on patient experiences measured in near-
real time at pain episodes, allow for adaptation of treatment as it progresses, and measure the impact
on outcomes of coping changes over the long-term. The results will shed light on active mechanisms of
treatment for TMD and may have implications for the management of other chronic pain conditions.

Public health relevance
TMD-related pain is a widespread chronic pain problem, affecting not just the patient, but the family and the healthcare system at large. A treatment program that helps the patient more effectively develop coping skills can create the conditions necessary for long-term treatment success. Results from this project are expected to shed light on mechanisms of pain treatment and to translate to other chronic pain problems.